Cognitive and Neurobiological Approaches to Plasticity (CNAP) Center Phase 2

PROJECT SUMMARY: OVERALL
The goal of this Phase 2 COBRE application is to continue to develop a unique, nationally recognized,
thematic research center on Cognitive and Neurobiological Approaches to Plasticity (CNAP). We will build on
Phase 1 successes by further enhancing research infrastructure and continuing to build a critical mass of
investigators studying cognitive and neural plasticity. We will continue to develop the plasticity thematic focus
of the center by supporting research in three new cross-cutting thematic areas: The Neurobiology of Learning
and Memory, Neuromodulation and Assessment, and Advanced Computational Modeling. The cross-cutting
themes bridge across animal models and human translational research, and across disciplines. The cross-
cutting themes reflect the planned enhancements of the research cores, knit together the current projects, will
guide priorities for faculty recruitment and future pilot grant and replacement project grant selection, and will
inform future program development initiatives. Further development of the CNAP center and its associated
programs will propel us toward achieving our goal of improving cognitive and neural functioning in both healthy
populations and in individuals with specific diseases or disorders. CNAP center development will be advanced
through the achievement of four specific aims: (1) To promote R01 award success for CNAP project and pilot
grant leaders. In Phase 2, we will support three new research project leaders who have strong potential to
transition to R01-level support. In addition, following the success of our active pilot grant program in Phase 1,
we will continue to fund pilot grants annually in Years 2-5, providing further opportunities for graduation of
junior investigators to R01-level research support. (2) To continue to develop a critical mass of researchers in
cognitive/neural plasticity through recruitment of new CNAP members. We will recruit three new tenure-track
faculty in research areas relevant to the CNAP cross-cutting themes. We will further expand CNAP
membership by funding new pilot grants and expanding the research cores. (3) To further improve research
infrastructure by expanding three multi-user core laboratory facilities. We will expand the Behavioral
Neuroscience Core, Cognitive Neuroscience Core, and Neuroinformatics Core by adding significant new
capabilities to promote access to modern neuroscience and computational modeling techniques. (4) To
enhance the research capabilities of CNAP center members through strengthening the Scientific Exchange
Network (SEN). The SEN will provide CNAP researchers access to additional core facilities and training to
increase their capability to secure extramural funding. Achieving these aims will further advance a thriving
thematic research center that will increase the understanding of cognitive and neural mechanisms of plasticity.
CNAP will attract extramural funding through individual investigator and partnership grants, will promote a rich
research climate for fostering investigator development, will continue to enhance research infrastructure, and
will provide a pathway to long-term center sustainability by the end of Phase 3.

Public health relevance
PROJECT NARRATIVE: OVERALL This COBRE Phase 2 application proposes to continue to develop a unique, nationally recognized, thematic research center on Cognitive and Neurobiological Approaches to Plasticity (CNAP). Plasticity refers to the brain’s ability to change and adapt throughout life. CNAP researchers, supported by three multi-user core facilities, will study various aspects of plasticity in humans and animals using a range of research techniques.